Biomedical Resource Core

SUMMARY-BIOMEDICAL RESOURCE CORE
A major unmet challenge in kidney research is the inability of most traditional approaches and methods to
harness the complexity of tissue function, structure, and cellular phenotypes. Innovations in nanotechnology
provide powerful tools, reagents, and platforms that outperform traditional approaches in several areas of
medicine, as clearly shown by stunning successes including mRNA vaccine development and oncology.
Nevertheless, these resources are largely untapped by the kidney community and are unavailable in individual
labs or institutions. Northwestern University (NU) is home to global leaders and pioneers in nanotechnology
housed in the International Institute of Nanomedicine (IIN). During the tenure of the Northwestern O'Brien Kidney
Center (NU-GoKIDNEY), we leveraged this unique scientific expertise at NU to establish and optimize services
that deploy the power of nanotechnology in the service of kidney researchers in their efforts to develop more
effective treatments for kidney diseases. The proposed Core builds on the momentum established through the
Core B nanotherapeutic services offered by NU-GoKIDNEY, which includes 1) longstanding commitment to
kidney research of nanomedicine leaders at NU who served as Core leaders and members of our Executive
committee, 2) demonstrated interest in nanotechnology services by kidney investigators who requested
nanotechnology services and submitted P&F proposals focused on nanomedicine solutions. These established
services now form the basis of the following Specific Aims: Aim 1 will establish a Biomedical Resource Core
to implement a service design for precision targeting of desired payloads to specific cells and sub-regions within
the kidney; Aim 2 will establish SOPs and implement internal QA/QC and SOP protocols for all services offered;
Aim 3 will ensure national access to resources by multiple mechanisms, that operate in collaboration with the
consortium. In summary, the NU- Biomedical Resource Core will harness the power of nanotechnology to
advance kidney health and provide an easily accessed portal to Core services for investigators throughout the
US.